Tobacco and Alcohol Use Trajectories in Sexual-Minority Emerging Adults

PROJECT SUMMARY Emerging adults, often referred to as people between the ages of 18 and 25 years,1,2 report a high prevalence of past-month cigarette smoking and heavy episodic alcohol use compared to other age groups in the U.S.3-6 Sexual minorities (SM; including lesbians, gays, and bisexuals, and those with same-sex behaviors attractions, or relationships) in emerging adulthood are more likely than their completely heterosexual peers to be current or daily smokers7-12 and to engage in heavy episodic drinking.12-15 These sexual-orientation disparities begin in adolescence7,13,16 and persist into later stages of the life course.17-20 Despite pronounced disparities in substance use for SM populations, there are few investigations about substance use trajectories in emerging adulthood for SM populations and how substance use during this transitional period impacts health and adjustment in later emerging adulthood. Furthermore, there is only limited understanding about the early risk factors of substance use for SM emerging adults. Accordingly, the proposed study will employ a developmental perspective45-47 to empirically test how early risk and protective factors across several domains predict tobacco and alcohol use trajectories in emerging adulthood for SM populations, and how these trajectories are, in turn, related to health consequences and adult adjustment outcomes in later emerging adulthood. Analyses will use data from SM participants collected principally during emerging adulthood in the Growing Up Today Study (GUTS), a large national cohort study begun in 1996. The Specific Aims are to do the following: 1) Estimate trajectory patterns of tobacco and alcohol use for SM populations during emerging adulthood; 2) Elucidate antecedents from childhood and adolescence that predict tobacco and alcohol use trajectory group membership; and 3) Measure the health consequences and adult adjustment outcomes of tobacco and alcohol use trajectory groups. The proposed Specific Aims are consistent with the goals of the National Institute on Drug Abuse (NIDA) and relate to NIDA's strategic plan to identify the characteristics and patterns of substance use and to understand how development influences the various risk and protective factors for substance use with the ultimate goal of preventing the initiation and escalation of substance use. To facilitate such research, the applicant will execute a training plan that builds and improves upon his knowledge and skills in longitudinal study design and data analysis, substance use and prevention research, human development theories and research, and SM health research. The applicant will conduct the proposed research with support from a dedicated and multidisciplinary mentorship team in a resource-rich environment at the University of Pittsburgh. Upon successful completion of this fellowship, the applicant will be well-poised to meet his long-term goals of attaining a faculty position and having an independent scientific research career in substance use and prevention with specialties in young SM populations.

Public health relevance
PROJECT NARRATIVE This project will enhance our understanding of important predictors, both risk and protective factors, of tobacco and alcohol use trajectories (and related consequences) during emerging adulthood for sexual-minority populations. This information will inform the development of effective interventions that prevent or reduce tobacco and alcohol use and related consequences, which may ultimately lead to health equity for sexual- minority populations. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Emerging adults, often referred to as people between the ages of 18 and 25 years,1,2 report a high prevalence of past-month cigarette smoking and heavy episodic alcohol use compared to other age groups in the U.S.3-6 Sexual minorities (SM; including lesbians, gays, and bisexuals, and those with same-sex behaviors attractions, or relationships) in emerging adulthood are more likely than their completely heterosexual peers to be current or daily smokers7-12 and to engage in heavy episodic drinking.12-15 These sexual-orientation disparities begin in adolescence7,13,16 and persist into later stages of the life course.17-20 Therefore, SM populations are at substantial risk for negative health consequences of substance use, such as substance disorders21,22 and high-risk sexual behaviors leading to unintended pregnancies, sexually transmitted infections, and HIV infection23-25-all of which disproportionately affect some SM subgroups.26-30 Additionally, high substance use trajectories have been linked with adult adjustment problems, including lower educational attainment.31,32 Despite pronounced disparities in substance use for SM adolescents and adults, there are few investigations about substance use trajectories in emerging adulthood for SM populations and how substance use during this transitional period impacts health and adjustment in later emerging adulthood. Some research has identified early risk and protective factors that influence substance use in SM populations. Sexual, physical, and psychological abuse before age 18 partially explained why SM emerging adults have elevated risk for substance use and disorders.33-36 On the other hand, having adult support, access to SM-specific resources (e.g., resource centers), more SM close friends, and low internalized homophobia are associated with lower substance use among SM populations.37-44 However, these investigations are often limited by cross-sectional study designs and examinations of a single developmental time point. The proposed study will employ a developmental perspective45-47 to empirically test how early risk and protective factors across several domains predict tobacco and alcohol use trajectories in emerging adulthood for SM populations, and how these trajectories are, in turn, related to health consequences and adult adjustment outcomes in later emerging adulthood. The proposed research builds directly on the work of Co-Sponsor Dr. Heather Corliss and colleagues,7,13,48 which used between-group analyses (i.e., comparing SMs to completely heterosexuals) and found large disparities in substance use adversely affecting SM adolescents. The proposed study will employ within-group analyses to more finely characterize tobacco and alcohol use trajectories in SM emerging adults, along with their antecedents and consequences. Analyses will use data from SM participants collected principally during emerging adulthood in the Growing Up Today Study (GUTS), a large national cohort study begun in 1996. The Specific Aims are to: 1) Estimate trajectory patterns of tobacco and alcohol use for SM populations during emerging adulthood. Growth mixture modeling, an advanced statistical procedure for empirically identifying heterogeneous trajectory groups, will be used to model longitudinal tobacco and alcohol use separately. Analyses will also examine the joint distribution of tobacco and alcohol trajectories. We hypothesize that different trajectory groups characterized by high and low tobacco and alcohol use will be identified. 2) Elucidate antecedents from childhood and adolescence that predict tobacco and alcohol use trajectory group membership. Analyses will test the following hypotheses: 2a) Those who have the presence (vs. absence) of risk factors (e.g., abuse, substance use initiation) at younger ages are more likely to be in a high substance use trajectory group; 2b) High levels of adult support will buffer the negative consequences of risk factors (e.g., among those who experienced abuse, those with high levels [vs. low levels] of adult support will be more likely to be in a low use trajectory group); 2c) Those with positive (vs. negative) SM experiences (e.g., low or no internalized homophobia, more connection to SM community resources) at multiple time points are more likely to be in a low use trajectory group. 3) Measure the health consequences and adult adjustment outcomes of tobacco and alcohol use trajectory groups. Analyses will test the following hypotheses: 3a) High (vs. low) substance use groups will be more likely to report substance disorders and poorer adult adjustment (e.g., lower educational attainment); 3b) For alcohol use trajectories, high (vs. low) use groups will be more likely to report sexual behaviors, pregnancies, and sexually transmitted infections. This study will identify consequences of the development of substance use for young adult adjustment and modifiable factors that significantly prevent or reduce substance use and related consequences for SM populations. Because few, if any, substance use interventions exist for SM populations,27 this research will provide necessary information for designing interventions by generating evidence about where, when, and to whom interventions should be targeted. By informing culturally and age-appropriate interventions, this research has the potential to increase the resources of SM populations and reduce sexual-orientation disparities in substance use. The proposed research is a necessary next step in the process for achieving Healthy People 2020's goal of health equity for SM populations.49